Impact of excitatory synapse maturation on synaptic plasticity and stability

Project Summary/Abstract As per the guidelines, the research plan includes the project summary/abstract of the funded parent award.

Public health relevance
Project Narrative Recent findings from our lab show that loss of phospho-Y1252 impede Nck2 from binding, which is associated with a reduction in dynamic actin in the spine, and with reduced GluN2B-NMDAR activity. This suggests an important interaction between GluN2B subunits and dynamic actin for GluN2B-containing NMDARs. The project I propose here will elucidate the biochemical underpinnings of a novel GluN2B:actin interaction, the impact of the GluN2B tail on actin filament polymerization, actin filament stability, and how manipulations of the actin binding interface in the GluN2B cytoplasmic tail impact the function of GluN2B- containing NMDARs.